Mechanisms of Left Right Organizer Development

Summary Statement
In vertebrates, motile cilia within the Left-Right Organizer (LRO) are pivotal for a developing organism’s left
right axis formation, such as cardiac left-right development. Evidence from model organisms, like zebrafish
LRO, highlights conserved cilia-driven leftward flow crucial for regulating target genes controlling asymmetric
heart morphogenesis. LRO cells are made up of both motile and non-motile cilia with one population required
for fluid flow generation and the other potentially for fluid sensing. Open questions that exist are: What are the
mechanisms by which cells determine whether to develop motile or non-motile cilia within an LRO? What are
the specific roles played by each of these cilia populations in development? However, answering these
questions in mammalian LRO development is hindered by technical challenges, limiting real-time analysis of
spatial cell arrangements, cytoskeletal characterization, cilia assembly, and transcriptional landscape
exploration. We aim to address these challenges using Danio rerio (zebrafish) LRO to test our hypothesis:
spatial and temporal cell division regulation guides intracellular and cellular remodeling essential for LRO
maturation and function. Our R35 application encompasses two projects. Project 1: Assessing the impact of
each LRO cell division event on LRO development. Here we will investigate cell redistribution mechanisms and
the dominance of specific progenitor cells in LRO formation, addressing cell lineage and cell behavior
questions. Additionally, comprehensive gene expression analysis across LRO developmental stages will
identify key genes and pathways guiding LRO development. We will employ cell tracking, microtubule labeling
with laser ablation, and transcriptomic profiling to understand mitotic events crucial for LRO development.
Project 2: Characterizing mechanisms involved in microtubule pattern formation and reorganization during
LRO development in relation to actin reorganization, tight and adherens junctions, and cilia formation. Utilizing
live cell imaging, molecular and genetic manipulations, array tomography and AI, we will characterize LRO cilia
localization and structure at rosette and lumen stages to identify models for LRO development events and fluid
flow sensing. Success in addressing our outlined objectives in unraveling the temporal and spatial mechanisms
coordinating cell division, intracellular remodeling, gene expression, polarity formation, junctional protein
formation, and cilia ultrastructure during LRO development will position us to define how an LRO is assembled
and provide novel models that can be tested for how other ciliated tissues develop.

Public health relevance
Project Narrative: This proposal supports the Hehnly lab's goal of understanding the assembly of the Left Right Organizer (LRO), crucial for establishing vertebrate left-right body symmetry. Investigating temporal and spatial mechanisms coordinating cell division, gene expression, polarity, and cilia ultrastructure during LRO development will provide new insights into ciliated tissue development.